Molecular regulators of GABAergic systems that underlie comorbidities in Down syndrome

PROJECT SUMMARY
Down syndrome (DS), which is caused by full or partial trisomy of human chromosome 21 (Hsa21),
presents various neurological features, including intellectual disability, epilepsy, and Alzheimer’s disease
(AD). Although some Hsa21 genes have been identified as key contributors to some of these diseases, the
pathogenetic mechanisms that link the triplication of HSA21 genes to most DS-related diseases remain
unknown. Particularly, very little is known about whether any of these diseases share common mechanisms.
For example, we do not know whether the increased risk for epilepsy and cognitive deficits share common
molecular and cellular basis. This is a major gap in our understanding and impedes the development of
effective treatments of DS-related diseases. Many of the DS-related neurological conditions are related to
dysregulated GABAergic systems. Previous studies by others and ours have shown that excessive
functions of GABAergic synapses impair synaptic plasticity in the hippocampus and the cognitive
performances in DS mouse models. On the other hand, dysregulated GABAergic systems are also a major
contributor to epilepsy. These results indicated that GABAergic dysfunction and altered connectivity might
be key to the comorbidity of cognitive deficits and epilepsy in DS. Recently, we found that the triplication of
Down syndrome cell adhesion molecule (DSCAM) is a major cause of the increased GABAergic synapses
and enhanced GABAergic synaptic transmission in the neocortex of DS mouse models. DSCAM variants
are strongly associated with cognitive abilities, raising the possibility that DSCAM contributes to the
comorbidity of DS diseases that are caused by dysregulated GABAergic systems. The objective of the
proposed study is to identify molecular regulators of GABAergic systems that underlie comorbidities in DS.
The central hypothesis is that DSCAM triplication enhances GABAergic synaptic transmission by increasing
GABAergic synaptogenesis and contributes to the comorbidity of cognitive deficits and epilepsy in DS. The
collaborative team has complementary strengths and is in a unique position for the proposed study. The
proposed research is innovative because it will (1) identify a novel molecular mechanism that underlies the
comorbidity of cognitive deficits and epilepsy in DS; (2) provide the first complete characterization of the
activity dynamics of cell-type specific populations of the DS hippocampus in vivo; (3) apply cutting-edge
spatial transcriptomic techniques to provide a unique transcriptomic profile with spatial resolution in a DS
mouse model. This research is significant because its successful completion will identify the molecular
regulators of the GABAergic system in the DS hippocampus and discover them as common contributors to
the comorbidities between epilepsy and intellectual disability in DS. This knowledge will offer insights into
the development of therapeutic treatments that target these DS-related conditions. The knowledge will also
provide insights into other neurological disorders.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will identify molecular regulators that underlie comorbidities in Down syndrome, which will offer insights into the development of therapeutic treatments that target these conditions. It will also provide molecular and cellular insights into other neurological disorders, such as intellectual disabilities, epilepsy, and ASD. Thus, the proposed research is relevant to NIH’s mission because it is expected to develop fundamental knowledge that will help to reduce the burdens of disease and disability.